Multidimensional Sleep Health Intervention to Optimize Concussion Recovery: A Randomized Clinical Trial

Project Summary
Concussion is defined as a mild traumatic brain injury induced by biomechanical forces accompanied by an
alteration in neurological status. Concussion recovery is complex, and many factors influence short- and long-
term recovery outcomes. Among the deleterious effects observed after concussion, sleep-related problems are
commonly reported and associated with increased risk of developing persisting post-concussion symptoms.
Insufficient sleep is also commonly reported among uninjured adolescents, independent of concussion. In
combination, adolescents with concussion are uniquely vulnerable to immediate and persisting sleep deficits.
Currently prescribed sleep health recommendations for adolescents with a recent concussion remain vague,
with limited evidence supporting intervention guidance. Given the documented relationship between post-
concussion sleep problems and poor recovery outcomes, a multidimensional and prescriptive sleep health
intervention initiated within the first month of a concussion may lead to improved patient outcomes. Using both
patient-reported and objective (actigraphy) methods, our measurement approach will allow us to determine the
efficacy of an innovative intervention to improve overall sleep health, concussion recovery, mental health, and
academic engagement. The multidimensional sleep health intervention provides targeted and prescriptive
recommendations for the patient and is developed from our existing pilot work. Specifically, the intervention
addresses five areas with evidence to support post-concussion sleep deficits, including: 1) reduced time asleep,
2) inconsistent sleep/wake time, 3) more bed use for non-night-sleep purposes (e.g., napping), 4) excessive
screen time before bed, and 5) night-time anxiety. Participants will be randomized to a multidimensional,
prescriptive sleep health intervention or standard-of-care at Visit 1 (pre-intervention), undergo actigraphy
monitoring and complete daily surveys for two weeks, return for re-assessment two weeks after Visit 1 (Visit 2,
post-intervention), and 8 weeks after Visit 1 (Visit 3, persisting effects evaluation). Therefore, our objective is to
discover if a multidimensional sleep health intervention among adolescents with a concussion (1) leads to faster
symptom resolution time and better sleep quality and/or duration; and (2) affects persistent sleep habits, mental
health, and academic engagement. We will use a two-group randomized clinical trial design (intervention,
standard-of-care) with 3 assessments over an 8-week monitoring period. Our multidisciplinary investigative team,
with expertise in concussion management, RCTs among adolescents with concussion, clinical trial design, and
adolescent sleep behavior and psychology provides necessary experience to successfully complete this study.
By challenging current sleep recommendations provided for adolescent patients with concussion, our project
seeks to advance rehabilitation strategies for improved concussion management and overall improved health.

Public health relevance
Project Narrative Following adolescent concussion, poor sleep health is common and relates to the development of persisting post-concussion symptoms, and uninjured adolescents (independent of concussion) also commonly experience sleep insufficiency. Given the sparse guidance that exists for clinicians to provide evidence-based sleep health recommendations for adolescents with a concussion, the primary objectives of this prospective randomized clinical trial of adolescents with a recent concussion are to discover if a multidimensional and prescriptive sleep health intervention leads to: 1) faster symptom resolution time, better sleep quality, or longer sleep duration; and 2) improved sleep habits, mental health, or academic engagement, relative to standard-of-care post-concussion sleep health guidance. Findings from this research will provide the basis for more precise sleep health recommendations for adolescents who experience a concussion.